Weight Loss and Endocrine Disrupting Chemicals (EDCs): Lifestyle interventions to lose weight and reduce EDC exposure in individuals with overweight/obesity

ABSTRACT
The rising rates of obesity and metabolic disorders are a major health concern1 with an medical cost of $260
billion annually in the US.2 While poor diet/lack of exercise contribute to this issue, it doesn’t explain it fully.1,3,4
Many harmful endocrine disrupting chemicals (EDCs) act as “obesogens,” environmental chemicals that alter
metabolic endpoints and promote fat deposition.3 Increased BMI has been associated with increased EDC
levels,5,6 and higher EDC levels at baseline have been associated with a greater increase in body weight over
time7 and greater difficulty achieving and maintaining weight loss.8–10 It has been estimated that EDC-related
obesity/ metabolic disease costs the US $5.4 billion annually.11 While there are several digital weight-loss tools
and programs currently available to treat obesity, there are very few tools that allow individuals to track and
reduce their daily EDC exposures. Million Marker (MM), a science-based health and wellness company,12
offers the first effective direct-to-consumer EDC testing and intervention program.13 It is known that
behavioral interventions can both promote weight loss in adults with obesity14,15 and reduce their non-persistent
EDC exposures in urine.16–18 However, it is unclear if 1) weight loss programs can reduce EDC exposures, or if
2) EDC reduction intervention can result in weight loss. Thus, we propose a two-armed, randomized clinical
trial to examine these relationships in individuals with overweight/obesity. We will, 1) determine if MM’s
16-week EDC intervention program (EDC testing and report-back, EDC reduction curriculum, and group
coaching) can reduce weight; 2) determine if a 16-week validated digital weight loss program (Noom)14 can
reduce EDC exposures; and 3) compare the effectiveness of the two interventions at reducing weight and
urinary EDC metabolites. All three aims will assess EDC metabolites and weight loss, as well as the effects of
the interventions on improving EDC and weight related health literacy, readiness to change, adoption of
healthy behaviors, and wellness (stress, sleep, general health, physical activity, social support, and financial
well being), assessed via validated surveys before and after the interventions. Urinary EDC metabolites will be
measured via MM mail-in EDC testing kits pre- and post-intervention.16 We hypothesize that post-intervention,
participants in both arms will have reduced EDC exposures and weight, as well as improved health literacy,
readiness to change, healthy behaviors and wellness. The results of this Phase I pilot will enable the larger
Phase II study, in which we will examine the interaction of both interventions in order to determine whether the
combination results in greater weight loss and greater EDC reduction than either intervention alone. Additional
clinical endpoints (e.g. cholesterol, HbA1c, inflammatory markers) will also be investigated in the Phase II
study. We will also be well situated to increase our study sample size as well as recruit more racially/ethnically
diverse participants in the Phase II study, in preparation for commercialization of the EDC testing and
intervention program among clinics, employee wellness programs, and large healthcare systems and insurers.

Public health relevance
Project Narrative This research study aims to improve the health of individuals who are overweight/obese by providing testing for exposure to harmful environmental chemicals known as EDCs (endocrine disrupting chemicals) and providing weight loss intervention or EDC reduction intervention. We will test the effectiveness of the two 16-week interventions in 80 individuals who are overweight/obese (40 receiving each intervention) through pre- and post-intervention analysis of urinary EDC metabolites and surveys that assess self-reported weight, EDC and weight related health literacy, readiness to change (chemical exposures and dietary behaviors), self-reported behavior change (e.g. ate fewer packaged foods, ate out less), and wellness (stress, sleep, general health, physical activity, social support, financial well being).